IMPROVE AKI: A Cluster-Randomized Trial of Team-Based Coaching Interventions to IMPROVE Acute Kidney Injury

PROJECT SUMMARY We propose to test the implementation of evidence-­based preventive interventions through a Virtual Learning Collaborative (VLC) with and without the novel use Automated Surveillance Reporting (ASR) intervention to change clinical practice and improve patient safety in common diagnostic procedures. Over 2 million people in the United States undergo diagnostic or interventional cardiac catheterization each year. Acute kidney injury (AKI), a patient safety metric set by the National Quality Forum, occurs in up to 14% of all patients following a procedure and up to 50% in patients with pre-­existing chronic kidney disease (CKD), making AKI the most prevalent adverse event. Patients developing AKI have an increased risk of serious adverse events. There are widely accepted interventions to prevent AKI in patients undergoing cardiac catheterization. Our research team has demonstrated AKI can be prevented in 28% of patients with CKD through a large regional pilot. Our team has already developed ASR techniques for AKI nationally within the Veterans? Administration. Based on our own preliminary studies, we hypothesize the incorporation of an automated plug-­in ASR toolkit to provide near-­ realtime feedback to front-­line care teams will significantly augment both VLC and Technical Assistance (TA) interventions in implementation trials. Our objective is to conduct a national randomized clinical trial testing the use of VLC or TA with or without a plug-­in ASR toolkit to determine if ASR significantly improves outcomes for patients undergoing procedures with contrast dye to overcome the inconsistent application of known ways to prevent AKI. The rationale underlying the project is that ASR could prove to be a plug-­in vehicle to improve patient endpoints in evidence-­based preventive interventions in common diagnostic procedures. We plan to test our hypothesis through the following specific aims in a 2x2 factorial cluster-­randomized trial. For all aims, 16 hospitals will be randomized to receive one of the following interventions for 18-­months: A) Technical Assistance (TA);? B) Technical Assistance with Automated Surveillance Reporting (TA+ASR);? C) Virtual Learning Collaborative (VLC) with team-­based coaching (VLC);? and D) Virtual Learning Collaborative with Automated Surveillance Reporting (VLC+ASR). Specific Aim 1: Compare the efficacy of a VLC and/or ASR compared to TA to reduce the incidence of AKI. Specific Aim 2: Evaluate the sustained efficacy of VLC and/or ASR to reduce the incidence of AKI following the intervention period. The interventions proposed use novel interactive video coaching sessions and ASR as low-­cost scalable implementation strategies to prevent a clinical endpoint (AKI). Eighteen hospitals have agreed to participate and be randomized. We expect the impact of a plug-­in ASR to augment evidence based preventive interventions and VLC could significantly improve the consistent application of these interventions and implementation trials. In our opinion, our study will open the door to a new paradigm of implementation science seeking to continuously improve health care.

Public health relevance
PROJECT NARRATIVE When a person has an imaging procedure that uses radio- contrast dye, there is a possibility of damage to that person’s kidneys, which could result in being on dialysis or early death. We are testing novel coaching and automated tools to help healthcare teams apply approaches that have been shown to prevent damage to kidneys during a cardiac catheterization procedure. The results of our study will help inform health care leaders on how to implement low- cost preventive strategies through team- based coaching and surveillance reporting for kidney injury and other patient safety priorities to every hospital in the United States.